Micro RNAs as biomarkers and therapeutic targets in myotubular myopathy

PROJECT SUMMARY Myotubular myopathy is a fatal neuromuscular disease associated with severe morbidities (including wheelchair and ventilator dependence) and early mortality. There are critical barriers hindering treatment for this devastating disease. These include the need to uncover new therapeutic strategies, particularly ones with applicability for a broader spectrum of congenital myopathies, and to develop non-invasive biomarkers that correlate with treatment response and are thus suitable for use in clinical trials. Our overarching goal is to translate therapies for MTM. In this proposal, we will address this goal by establishing the first serum biomarker for MTM and identifying a novel therapeutic approach with broad treatment potential. MTM is an X-linked disorder caused by mutations in MTM1, a phosphatase that regulates endosomal sorting. We have shown that MTM1 mutation results in disruption of the triad, a muscle structure responsible for excitation-contraction coupling, and that triad disorganization is a critical driver of MTM pathogenesis. Several groups have demonstrated that myofiber hypotrophy is also an important contributor to MTM pathology. While the precise mechanisms underlying these changes remain to be elucidated, overexpression of DNM2 is a key driver of the triad defects, and unbalanced AKT-TOR pathway signaling is associated with the reduced myofiber size. In this study, we propose a treatment aimed at targeting and correcting these defects. MicroRNAs (miRNAs) are small, non-coding RNAs that modulate gene expression and serve as important regulators of myriad cellular processes. MiRNAs are emerging as both treatment effect biomarkers and potential therapeutics. In several disorders (including other muscle diseases), circulating miRNAs correlate with disease severity and treatment response, and are under consideration as biomarkers in clinical trials. The miRNAs miR-486 and miR-133a have direct relevance to MTM pathogenesis. We have shown that miR- 486 regulates myofiber size by rebalancing AKT signaling, and others have demonstrated that miR-133a directly down-regulates DNM2. These miRNAs are thus attractive as potential therapeutic targets, a concept validated by our demonstration of miR-486 overexpression as a treatment strategy for DMD. In preliminary data, we profiled miRNAs from MTM mouse muscle and found significant changes in 50 miRNAs including downregulation of miR-486 and miR-133a. Based on this, we hypothesize that changes in the levels of miRNAs will correlate with disease status and treatment response, and thus function as an ideal non-invasive biomarker for MTM. Further, we predict that restoring expression of miR-486 and miR-133a will increase myofiber size and reverse triad defects respectively, and thus rescue the MTM phenotype. We will test these hypotheses using rigorous methodology in the murine model of MTM. Successful completion of our study will identify the first biomarker of MTM suitable for clinical translation, and establish a novel treatment with applicability to muscle diseases that feature myofiber hypotrophy and/or triad defects.

Public health relevance
PROJECT NARRATIVE Developing non-invasive biomarkers and new treatment strategies for myotubular myopathy (MTM), a devastating muscle disease of childhood, are critical unmet medical needs. We hypothesize that circulating serum miRNAs correlate in MTM with disease severity and treatment response and thus are ideal biomarkers, and that two specific miRNAs (miR486 and miR133a) are instrumental to disease pathogenesis and thus targets for therapeutic intervention. We will test these hypotheses in two aims that capitalize on existing resources and investigator expertise; successful completion of these aims will identify the first biomarker for MTM and uncover a novel treatment strategy with broad applicability.